Implementation and Effectiveness of Patient Reported Outcome Measures for Peripheral Arterial Disease

ABSTRACT
Peripheral artery disease (PAD) is the one of the most common causes of morbidity and mortality for adults in
the United States. The number of patients needing surgical management for this condition is expected to nearly
double over the next 30-years. Patients with symptomatic PAD are referred to vascular surgeons who have two
potential treatment options: operative management via revascularization or non-operative management via
supervised exercise therapy. Despite symptomatic relief as the primary goal for treatment, there are no objective
outcomes used in PAD care to reflect patient’s perspective. Patient reported outcome measures (PROMs) are
validated, robust tools that objectively measure patient outcomes from the patient perspective and help deliver
patient-centered care. PROMs are used to monitor health changes across other medical conditions and contexts,
the utility of PROMs in patients with PAD has not been well-established. Traditionally, vascular surgeons have
used objective metrics, like ankle-brachial index (ABI) blood flow measurements, to evaluate progress and
determine the success of an intervention. Despite the widespread availability of PROMs, it is presently unclear
how these metrics can be used to in the clinic workflow and healthcare delivery of patients with PAD. The central
goal of this research is to develop a successful implementation strategy for PROMs as a patient voice
into routine clinical care for PAD. More specifically, we will examine how changes in physical function PROMs
and ABI influence each other dynamically over time (Aim 1.1) and then compare PROM changes over time for
physical function, depression, and social engagement in activities among operative and non-operative PAD
patients (Aim 1.2). Next, we will obtain patient perceptions and value of PROMs in PAD care using semi-
structured patient interviews (Aim 2). Finally, using a multilevel stakeholder advisory panel we will design a
strategy for implementing PROMs into routine clinical workflow for PAD patients using a modified-Delphi
approach (Aim 3). These data will provide essential contextual components (Aims 1 & 2) to help design a
successful strategy for PROMs (Aim 3) into routine clinical practice for patients with PAD. This work will lay the
foundation for future implementation efforts focused on use of PROMs at our institution and others. Our team is
uniquely qualified to carry out this research. We have prospectively collected PROMs since 2016 for research
and have the resources and clinical environment to implement changes in clinical practice. While executing these
aims, I will gain valuable knowledge using qualitative research methods, trajectory analysis, and established
implementation science frameworks. With the support of my mentorship team and the NRSA fellowship, I will
attain a unique skillset at the intersection of implementation science, surgery, and patient care that will provide
a solid foundation for future success as a vascular surgeon-scientist.

Public health relevance
PROJECT NARRATIVE The application of patient reported outcome measures (PROMs) for peripheral arterial disease (PAD) patients will allow for improved detection of health changes and incorporate a patient voice into PAD clinical care. This study fills contextual gaps for using PROMs in the healthcare delivery for PAD, provides a rigorous and replicable process for the identification of patient perceptions, and develops a strategy for meaningfully engaging stakeholders in the deployment of implementation strategies. The achievement of the proposed aims will produce a generalizable strategy to promote PROM clinical utilization and patient-centered care for PAD patients.